Rapid, Handheld, Point-of-Care Stool Sample-prep Device for the Extraction and Detection of Nucleic Acid from Diarrheal Pathogens

Abstract
Diarrheal disease is a major health issue worldwide resulting in nearly 500,000 deaths annually
in children under 5 years of age. Those who survive have higher risk of stunted growth and
cognitive development. Identification of the gastrointestinal (GI) pathogens that cause diarrheal
disease helps guide effective treatment. Currently, in the developed world, this is done using
multiplexed PCR laboratory tests which are expensive, slow and require a sophisticated high
complexity laboratory. Unfortunately, such laboratory tests are not available in remote and
resource limited regions in the developing world where mortality due to diarrhea is the highest.
Thus, we propose to develop an integrated, low-cost, point-of-care (POC) test to identify the GI
pathogens that cause diarrheal diseases. This test will be useful in resource-limited settings of
the developing world as well as in primary care and urgent care settings of the developed world
where it will be useful to detect the GI pathogens in real time, in the clinician's office so the
patient can be treated with the right drugs, right away, without loss of patients to follow up. The
major problem with detecting gastrointestinal (GI) pathogens is the complexity of stool samples,
often filled with particulate and molecules such as bile salts. Such contaminants can inhibit
signal amplification and detection if not properly removed from the sample. In previous SBIR
projects, GoDx has developed sample preparation chemistry, DNA amplification and detection
assays on lateral flow paper strips for a suite of GI pathogens. Our next step is to develop a
pathogen detection device that fully integrates sample processing and signal amplification,
which can be used rapidly at the point of care (POC). To achieve this, we propose to develop a
stool sample prep device that can robustly provide viable DNA for amplification and detection all
while requiring minimal user action to do so. The technology proposed here will be able to
extract and enrich DNA from a swab of stool in a matter of minutes without the need for
centrifuges or pumps. In Phase 2 of this project, we will fully integrate the GoDx’s amplification
and detection assays with the sample prep technology developed here, providing a seamless,
minimal step POC device for the detection of GI pathogens that cause diarrheal diseases
around the world.

Public health relevance
Project Narrative According to the World Health Organization, there are 1.7 billion cases of diarrheal diseases every year and approximately 1.5 million children’s deaths. The rapid identification of the pathogens that cause infectious diarrheal disease at the point-of-care (POC) may save lives and improve health outcomes by enabling prompt treatment with appropriate drugs. We propose the development of a low-cost, point-of-care stool sample preparation and DNA amplification and detection device to identify which pathogens are causing the infectious diarrhea so that patients can be treated at the clinician's office with the right drugs, right away even in resource-limited settings.